Mechanisms of pancreatic inflammation in obesity

PROJECT SUMMARY
Obesity produces a chronic pro-inflammatory state, and increases the risk for inflammation driven
pancreatic diseases, most notably acute pancreatitis, and pancreatic cancer. The exocrine pancreas
contains a high density of specialized macrophages and T cells that interact together, but little is understood
about how obesity affects pancreas immune cells and their role in driving pancreatic inflammation. We
therefore investigated how obesity affects pancreatic immune cells. Body mass index, a marker of adiposity,
correlates with the density of TRMs in the exocrine pancreas. Obese pancreas also shows a higher
proportion of pro-inflammatory macrophages expressing CD11c which interact with and increase T cell
activation. Deeper analysis with single cell sequencing revealed that macrophages with signatures of
embryonic origin have strong pro-repair functions, while those derived from bone marrow monocytes
upregulate CD11c and show pro-inflammatory properties. This suggests that during obesity, monocyte-
derived macrophages may contribute to inflammation, while embryonic macrophages attempt to maintain
tissue homeostasis. To test this hypothesis, we propose two specific aims. In aim 1 we will investigate how
the origin of pancreatic macrophages (embryonic vs. monocyte-derived) affects their function in obesity. We
hypothesize that monocyte-derived macrophages, differentiating in obese pancreas, are more pro-
inflammatory than embryonic macrophages or those found in lean individuals. To test this, we will isolate
and compare the macrophage lineages from obese and non-obese organ donors and analyze their cytokine
production and ability to activate T cells. Additionally, a mouse model will be used to track and compare
these macrophage populations in lean and obese mice. This will ultimately reveal the source of pro-
inflammatory macrophages during obesity. In aim 2 we will explore how monocyte-derived macrophages
contribute to pancreatic inflammation in obesity. We hypothesize that these macrophages exacerbate
inflammation and disrupt the normal function of embryonic macrophages. To test this hypothesis, we will
perform multiplex staining and immune spatial profiling of obese and non-obese human pancreas to
quantify the interactions of embryonic and monocyte derived macrophages with T cell rich inflammatory foci
that appear during obesity. Furthermore, a mouse model for the selective depletion of monocyte-derived
macrophages will be developed. This model will be used to study how depleting these macrophages affects
immune regulation and T cell interactions within the pancreas of obese mice. This research leverages
human data and mouse models for a deeper understanding of pancreatic macrophage origin, and function
during obesity, and their role in pancreatic inflammation. By addressing this critical knowledge gap, the
study holds promise for developing novel therapeutic strategies that target macrophages to prevent or treat
obesity-associated pancreatic diseases.

Public health relevance
PROJECT NARRATIVE Maintenance of robust and well-regulated pancreas tissue immunity is essential for human health, yet the mechanisms controlling pancreas immune function are poorly defined. Obesity dysregulates the immune control mechanisms of pancreas and leaves the organ susceptible to developing pancreatitis and pancreatic cancer. In this study, we will define how obesity upsets the function of pancreatic macrophages – an immune lineage that plays a key role in maintaining pancreas immune homeostasis and orchestrating its response to injury – to reveal new strategies for treating pancreatic disease.